Deciphering the Regulation of TGF-b3 in Driving Myofibroblast Differentiation in Systemic Sclerosis

SUMMARY/ABSTRACT
This application is for a K01 Mentored Research Scientist Development Award entitled “Deciphering the
Regulation of TGF-3 in Driving Myofibroblast Differentiation in Systemic Sclerosis”, submitted by Dr. Mengqi
Huang, a Research Instructor within the Division of Rheumatology and Clinical Immunology at the University
of Pittsburgh. The short-term goals detailed in this submission are designed to help the applicant achieve her
long-term objective of becoming an independent scientist and leader in the field of SSc research. These short-
term goals include (1) advancing knowledge of computational biology and disease rodent model (2) development
of technical and analytic tools to effectively identify and validate epigenetic targets, and (3) development of
leadership skills to obtain academic independence. This work will be completed in the Division of Rheumatology
and Clinical Immunology at the University of Pittsburgh, a rich research environment with a strong commitment
to and proven track record of fostering the development of medical research scientists. The central objective of
this research proposal is to investigate the epigenetic regulatory networks driving increased expression of TGF-
3 in SSc skin myofibroblasts, which are the key effector cell in fibrosis and no treatments currently exist to
target these cells. Increased transcription of TGF-3 has been shown a significant correlation with skin fibrosis
severity of SSc patients, and a newly published study showed that selectively inhibition of TGF-3 can sufficiently
reduce lung fibrosis in a SSc-relevant mice model. However, the regulation of elevated TGF-3 expression in the
pathogenic myofibroblasts remains unknown. My preliminary data implicates SSc myofibroblasts as the primary
source of TGF-3 in skin, and the FRA-2/FOSL2 transcription factors (TF) as putative positive regulators of
TGF-3 transcription. The primary hypothesis is that TGF-3 regulated by FOSL2 (and/or other TF) reflects the
underlying transcriptional landscape of myofibroblast differentiation and mediates SSc fibrosis. With this
proposal, the applicant will expand on her prior work with the following specific aims: (1) Identify the DNA cis-
regulatory element(s) of TGF-3 in SSc skin fibroblasts, (2) Investigate FRA-2/FOSL2 or other upstream
regulator(s) of TGF-3 in SSc patients by integrating transcriptomic and epigenetic profiles of skin fibroblasts at
the single cell level, and (3) Assess the importance of TGF-3 in driving fibrosis in relevant murine models of
SSc. This proposal will determine the role of TGF3 and its regulator FRA-2/FOSL2 (or other TF) in mediating
myofibroblast differentiation in vitro and organ fibrosis in vivo.

Public health relevance
NARRATIVE While significant strides have been made in unraveling the complex pathogenesis of systemic sclerosis (SSc), effective therapies targeting myofibroblasts, the primary cells driving fibrosis in SSc, remain elusive. Transforming growth factor β (TGFβ) is recognized for its central role in promoting myofibroblast differentiation in SSc. This study aims to investigate epigenetic mechanisms underlying the upregulation of TGF-β3, specifically expressed in skin myofibroblasts, with the goal of enhancing the safety and efficacy of SSc treatment by targeting the TGFβ signaling pathway.